Impact of gene-drive systems for population modification on malaria vector mosquitoes

Project Summary
While significant progress has been made in reducing the malaria burden since the turn of the century, the last
few years have seen a deceleration of this success and the World Health Organization (WHO) in its 2020 World
Malaria Reportestimates ~229 million cases (morbidity) and 409,000 deaths (mortality) in 2019.
Approximately 95% of the global malaria deaths occurred in only 31 countries with seven in sub-Saharan Africa
accounting for ~51% of all the deaths. Furthermore, the WHO predicts no further significant decreases without
greater use of the existing technologies and the necessary development of new tools. The challenges of the
continued demand for new drugs and the slow roll-out of an efficacious vaccine makes urgent the need for new,
cost-effective and efficacious disease-control tools that are safe for people and the environment. This need
justifies efforts to develop genetic approaches for controlling malaria parasite transmission. Long-term,
sustainable genetic control will require the deployment of strategies designed to be resilient to the immigration
of susceptible mosquitoes and parasite-infected people. Genetically-engineered mosquito strains for population
modification have the appropriate performance features for this purpose. Wild mosquitoes immigrating into a
region populated by engineered, parasite-resistant mosquitoes will acquire beneficial genes by mating with the
local insects, and persons with malaria moving into the same region will not be able to infect the resident
vectors, and therefore are not a source for infection of other people. We have exploited the molecular
mechanisms of CRISPR/Cas biology to develop autonomous gene-drive systems for site-specific, transgene
copy number amplification in the mosquito germline. These drive systems carry a cargo of anti-parasite
effector genes that prevent transmission of the parasites by the mosquitoes carrying them. The working
hypothesis is that these systems will be able to impact transmission dynamics even if they confer a genetic load
that impacts reproductive fitness. We shall investigate the impact of gene-drive system insertions on the
recipient mosquitoes to determine effects on reproductive success and drive and effector gene efficacy and
stability. Towards these ends, our Specific Aims are: 1) evaluate the impact of autonomous gene-drive systems
on the reproductive success of Anopheles gambiae ss. and An. coluzzii and 2) evaluate the multigenerational
stability of autonomous gene-drive systems in Anopheles gambiae ss. and An. coluzzii in laboratory cage trials.
The successful completion of these Specific Aims will inform plans and modelling for the future use of this
technology in malaria control.

Public health relevance
Project Narrative Further progress in the malaria eradication agenda requires novel vector control strategies to complement advances in prophylactic and therapeutic drug discovery and an effective vaccine. Long-term, sustainable impacts on the vector mosquitoes requires the deployment of strategies designed to be resilient to the immigration of susceptible mosquitoes and parasite-infected people. Approaches that couple genes that confer resistance to parasite transmission with mechanisms for spreading those genes through target mosquito populations hold great promise for contributing to the control of this major disease.